Harnessing low-field MRI and robotics to enable personalized incisionless prostate surgery

PROJECT SUMMARY/ABSTRACT
Objective: The overarching goal of our research is to replace invasive radical prostatectomy with targeted, mini-
mally invasive image-guided focal resection of prostate cancer. We propose to accomplish this by combining novel
low-ﬁeld MRI techniques with a new kind of surgical robot capable of delivering two needle-sized manipulators
into the prostate through a standard transurethral endoscope.
Signiﬁcance: 1 in 8 men will be diagnosed with prostate cancer in their lifetime, and it is second only to lung
cancer in the number of men it kills every year in the USA. The gold standard treatment, radical prostatectomy,
involves complications including all those of major surgery, as well as high rates of impotence and incontinence.
Recently, pioneering surgeons have noted the promise of patient-speciﬁc transurethral focal resection to reduce
complication rates. However the approach is currently fundamentally limited by the fact that cancerous tissue
cannot be visually differentiated from healthy tissue in endoscope images, forcing the surgeon to “guess” where
the cancer is, based on memory of preoperative MRI images. Ultrasound-MRI fusion cannot improve things,
since the ultrasound probe compresses the prostate, which collapses the urethra and precludes transurethral
interventions. We propose to eliminate the guesswork and enable accurate, precise, personalized focal resections
by fusing high-resolution preoperative MRI with intraoperative low-ﬁeld MRI and a novel robotic system.
Innovation: The central innovation of this project is to enable use of the emerging generation of inexpensive,
portable, and open low-ﬁeld MRI scanners to guide focal prostate resection. Additional innovation comes from
the robotic system which will enable precise and accurate use of imaging information. The robot will be the
ﬁrst MRI-conditional robot able to deliver multiple manipulators through an endoscope. It will feature needle-
sized, tentacle-like manipulators and deploy them into the prostate through a standard-diameter transurethral
endoscope, for precise resection and retraction of tissue. This will make the focal resection process much easier
and more accurate for the surgeon to accomplish.
Approach: We will create our MRI-guided robotic system through three Speciﬁc Aims. Aim 1 achieves fast in-
traoperative imaging to update the surgeon's image guidance display as they remove tissue. In Aim 2 we build
a novel MRI-conditional robot and integrate it with the low-ﬁeld MRI scanner. In Aim 3 we validate the integrated
system in anthropomorphic phantoms with urologic surgeons. Note that clinical translation of our system will be
rapid at the successful conclusion of this R01. This project includes two industry partners, Promaxo, Inc. which
has recently released an FDA-approved low-ﬁeld prostate MRI scanner, and Virtuoso Surgical, Inc. which is de-
veloping a (non-MRI-conditional) transurethral robot slated to be on the market by the time this R01 concludes.
Thus, successful completion of this R01 will pave the way for commercial translation and clinical trials, enabling
us to rapidly bring the beneﬁts of this research to doctors and their patients.

Public health relevance
PROJECT NARRATIVE Targeted focal resection of prostate cancer has the potential to eliminate the many complications associated with whole-gland removal, but usually cannot even be attempted, because cancerous tissue looks the same as healthy tissue in endoscope images. Fortunately, cancerous tissue is accurately identiﬁable in high-ﬁeld MR images, which opens the door to precise and accurate focal resections using a new kind of surgical robot capable of delivering two needle-sized instruments through a standard transurethral endoscope. By combining this new robot with a single-sided low-ﬁeld MRI scanner that can accurately guide the instruments to lesions identiﬁed in registered high-ﬁeld MR images, we will create a system with the potential to enable targeted, personalized, focal resections for patients who today have no alternative to radical prostatectomy.